Inhibition of virus replication by broadly-acting recombinant enhanced antiviral restrictors (REAVRs)

Project Summary: Zoonotic viral infections are responsible for the majority of emerging and re-emerging
infectious diseases in humans. The current strategies for controlling vector-borne virus transmission are
insufficient and additional strategies are urgently needed. Our long-term goal is to define and test recombinant
antiviral sensor/effector strategies that broadly inhibit known and emerging viruses to control or prevent vector-
borne and zoonotic viral diseases. The overall objective of this application is to develop Recombinant Enhanced
Antiviral Sensors (REAVRs), which combine virus-sensing domains with effector domains from different antiviral
proteins to create proteins with unique and broadly-acting antiviral activities. Our central hypothesis is that
combining diverse virus-sensing domains with effector domains from other antiviral proteins will make them more
effective and result in increased resistance against diverse viruses. The rationale of this proposed project is that
once this strategy of synthesizing modular, broadly antiviral recombinant proteins is established, they can be
applied to whole organisms that are important vectors for viral diseases. Based on strong preliminary data, the
central hypothesis will be tested by pursuing three specific aims: 1) generate and optimize REAVRs and evaluate
their antiviral effects in cultured cells; 2) identify and characterize dsRNA- and virus-induced promoters in
mosquito cells and in vivo; and 3) generate REAVR-expressing mosquitoes and test their antiviral effects against
arbovirus infections. Under the first aim, we will generate second generation REAVR proteins and test their
antiviral activity against a broad panel of viruses in established reporter, RNA integrity, and congenic cell culture-
based assays. In the second aim, we will use long-read and short-read RNA-seq strategies to generate a
validated, high-resolution analysis of Ae. aegypti transcriptional changes in response to poly(I:C) and virus
challenge and define promoters driving these responses. Under the third aim, we will use the CRISPR/Cas9
gene editing system to site-specifically insert the second generation REAVRs into transgenic mosquitoes under
control of various inducible promoters, including dsRNA-inducible promoters, and determine their effect on
mosquito sensitivity to a panel of arboviruses and virus transmission. The proposed research is significant
because the proposed strategy of enhancing the host immune response has great potential for the better control
of the transmission of zoonotic viruses and unlike current strategies will inhibit multiple different virus families.
This project is innovative because it introduces a novel approach to prevent virus transmission by combining
different antiviral sensing and effector domains, which is predicted to yield proteins with antiviral activities against
many types of viruses. Moreover, the identification of dsRNA-induced promoters will expand our foundational
understanding of arthropod immunology, and increase the repertoire of available mosquito promoters that could
be employed in the generation of transgenic mosquitoes. Taken together, this project is introducing an innovative
strategy for better control of zoonotic viruses that is expected to have a positive impact on the field.

Public health relevance
Project Narrative: Animal- and vector-transmitted viruses are major human health threats, and the primary source of emerging viruses. However, current strategies to reduce or prevent these sources of transmission are inadequate. The goal of this proposal is to generate recombinant antiviral proteins with enhanced antiviral activities, define more biologically relevant promoters to express antiviral genes in mosquitoes, and to test their effectiveness against model viruses in cultured cells and transgenic mosquitoes, ultimately resulting in a new, modular strategy to reduce or prevent transmission of a broad range of virus families.